Targeted Degradation of Mycobacterial PknG for Host Control of Tuberculosis

ABSTRACT
Mycobacterium tuberculosis (Mtb) is one of the world’s leading causes of death from infection. Curative
chemotherapeutic regimens exist, but they are long, often toxic and plagued by emergence of drug resistance.
Macrophages are the major cellular locale for Mtb in the host before formation of largely acellular cavities.
Adjunctive therapies could potentially speed the cure of tuberculosis by improving the ability of macrophages to
kill Mtb. Within macrophages, Mtb secretes an enzyme, protein kinase G (PknG), that enters the macrophage
cytosol, where it blocks fusion of lysosomes with phagosomes and promotes degradation of proteins that help
activate macrophage mycobactericidal mechanisms. Targeted protein degradation (TPD) is a promising new
therapeutic avenue. Compounds that mediate TPD differ from active site inhibitors by working catalytically and
therefore sub-stoichiometrically with respect to the target. TPD as a form of anti-mycobacterial chemotherapy
has been introduced for model targets in non-tuberculous mycobacteria, but not yet demonstrated for an Mtb
protein in its native state. Here we propose to exploit the macrophage’s ubiquitin-proteasome system to degrade
PknG as it has been secreted by Mtb and has entered the macrophage cytosol by synthesizing and testing
proteolysis-targeting chimeras (PROTACs) that link a PknG inhibitor to binders of the E3 ubiquitin ligases
cereblon and von-Hippel Lindau.

Public health relevance
NARRATIVE Tuberculosis (TB) is the single leading cause of death from infectious disease and new drugs are urgently needed to kill the causative agent, Mycobacterium tuberculosis (Mtb), within its predominant host cell niche, the macrophage. Mtb’s ability to replicate within the macrophage and break out to infect other cells depends on an Mtb enzyme called protein kinase G (PknG) that enters the macrophage cytosol. Here we will synthesize compounds to direct macrophage’s protein degradation machinery to degrade the invading Mtb’s PknG, thereby advancing the emerging concept of targeted protein degradation for anti-microbial development.